THE USE OF FORNASE ALFA (RHDNASE) IN RSV BRONCHIOLITIS

This study will evaluate the effect of rhDNase(dornase alpha) on young childerns that are hospitalized for RSV bronchiolitis. The hypothesis is that by liquefying the thick mucus of these patients, which occurs because of the bronchiolitis,via rhDNase that can lead to improving the outcome and could be a new way to treat bronchiolitis.